Contributions of de novo lipid synthesis to hematopoietic stem cell function

PROJECT SUMMARY/ABSTRACT
Hematopoietic stem cells (HSCs) can self-renew and generate all mature blood cells, allowing them to be used
for transplantation to treat hematological disorders. However, as many as 5-27% of patients experience poor
graft function, or incomplete hematopoietic recovery after transplant, which has only 6% 2-year overall survival.
This can be a direct result of defective HSC self-renewal and multilineage differentiation potential. However, the
specific pathways that regulate HSC function remain poorly understood. HSCs are mostly quiescent with low
metabolic and mitochondrial activity. They are activated into cell cycle and their mitochondrial activity increases
following transplant or 5-fluorouracil (5-FU)-induced myeloablation. Prior work in our lab has shown that after
replicative stress, HSCs have decreased regenerative ability, dysfunctional mitochondrial dynamics, and
decreased expression of metabolic genes such as stearoyl-Coa desaturase 1 (Scd1). SCD1 is an enzyme that
catalyzes the formation of monounsaturated fatty acids (MUFAs) in the de novo lipid synthesis pathway. These
products are used to form triglycerides and phospholipids that alter cell membrane structure, signaling, and
mitochondrial homeostasis. Specifically, lipids are necessary for proper mitochondrial membrane architecture,
dynamics, and oxidative metabolism. Our preliminary data demonstrate that pharmacological inhibition of SCD1
in HSCs in vitro significantly decreases their regenerative ability. SCD1 inhibition also leads to changes in
mitochondrial network structure. However, the contribution of MUFA synthesis to HSC function in vivo and why
HSCs depend on this pathway is unknown. Our central hypothesis is that MUFA synthesis is important for
maintaining HSC regenerative function by supporting mitochondrial function, and loss of this pathway
after replicative stress causes HSC functional decline. We will address this hypothesis by determining the
role of MUFA synthesis in HSC function in vivo (Aim 1) using an inducible SCD1 knockout mouse model. We
will then assess HSC regenerative function by serial competitive transplantation and recovery after 5-FU-induced
myeloablation. We will also determine the mechanism by which MUFA synthesis maintains HSC function (Aim
2) by assessing mitochondrial function and performing lipidomic and metabolomic analysis in SCD1-deficient
conditions. Using oleic acid, a product of the SCD1-catalyzed reaction, to restore MUFAs, we will determine
whether this improves HSC regenerative and mitochondrial function after replicative stress. These studies will
lead to a global understanding of the importance of MUFA synthesis to HSC function and reveal pathways that
can be targeted to improve HSC regenerative functions and clinical outcomes of HSC-based therapies.

Public health relevance
PROJECT NARRATIVE The success of hematopoietic stem cell transplantation (HSCT) relies on HSC activation and regeneration of the blood, and as many as 5-27% of patients have life-threatening defective blood cell production after transplant. HSC activation and cell division are associated with increased biosynthetic metabolism such as synthesis of lipids and proteins, but how these pathways regulate HSC function remains poorly understood. The goal of this proposal is to define the role of lipid synthesis in HSC function to identify targets to improve HSC regenerative potential and HSCT outcomes.